Single-cell Analysis of Glycomic and Proteomic Features of the HIV Reservoir

PROJECT SUMMARY: It has emerged in recent years that multiple types of HIV reservoir cells can persist in
the face of antiretroviral therapy (ART). HIV reservoir cells include those that are “latent” (transcriptionally-
inactive) and those that are transcriptionally-active. The transcriptionally-active reservoir cells may be a major
contributor to HIV rebound after ART interruption, as shown in analytic treatment interruption studies. In addition,
some reservoir cells are able to produce viral proteins upon stimulation (i.e., inducible reservoir cells), and these
reservoir cells may also be important for rebound as they are enriched for genome-intact and replication-
competent HIV provirus. Unfortunately, the lack of a detailed understanding of the cell surface phenotypes of
these HIV reservoir cells has precluded a full understanding of the biology of HIV persistence and hampered the
development of a cure. Importantly, prior efforts to characterize reservoir phenotypes all focused on cell surface
proteins and ignored cell surface glycans, despite the fact that glycans play a critical role in regulating multiple
key cellular processes and immunological functions and have served as useful biomarkers in many diseases.
We recently demonstrated that peripheral CD4+ T cells harboring high levels of fucosylated carbohydrates are
enriched for HIV+ transcriptionally-active cells and deficient in HIV+ transcriptionally-inactive ones, and that this
fucosylation is directly induced by HIV infection. These studies suggest that glycans may have utility as novel
biomarkers of specific types of reservoir cells. In this study, we combine newly developed single-cell surface
glycomic + proteomic technologies with bioinformatic analyses to analyze cells from an HIV latency model
and ART-suppressed HIV+ individuals in order better understanding the makeup of these cells, with the ultimate
goal of understand how they can persist in the face of ART and whether they express a unique profile of
therapeutically targetable biomarkers.
In Aim 1, we will test the hypothesis that cell-surface glycosylation patterns, including fucosylation, distinguish
transcriptionally-active and inactive HIV reservoir cells in vitro and in vivo. These studies will take advantage of
our recently established technique CyTOF-Lec, which pairs in-depth CyTOF phenotyping with surface glycan
characterization at the single-cell level. In Aim 2, we will examine the glycan features of in vivo inducible reservoir
cells. To do this, we will adapt our recently established and validated PP-SLIDE (predicted precursor single-cell
linkage using distance estimation) approach to characterize the glycan + protein features of patient-derived
reservoir cells inducible by ex vivo stimulation.
Together, these analyses will allow us to test our central hypothesis that specific cell-surface glycosylation
patterns, including fucosylation, can distinguish HIV reservoir cells from uninfected ones, and furthermore
distinguish different types of reservoir cells (e.g., latent, transcriptionally-active, and inducible).

Public health relevance
PROJECT NARRATIVE Cell surface sugars play an important role in regulating cell functions. Our preliminary data suggest that abnormal cell surface sugars and proteins may help to identify HIV-infected cells that persist and hide despite long-term therapy; this finding suggests abnormal sugars as a potential novel target for eliminating the HIV reservoir from people living with HIV. In this study, we will test these sugar molecules' ability to identify HIV persistently infected cells.